Construction of Conjunctival Equivalents Using Molecular Deposition Techniques

Abstract A1-R01 Grant Title: Construction of Conjunctival Equivalents Using Molecular Deposition
Techniques
A robust, functional conjunctiva with goblet, stratified squamous, and undifferentiated cells is critical for a
transparent cornea and a healthy anterior eye. Ocular surface disorders, including, infectious (trachoma),
autoimmune (ocular cicatricial pemphigoid), and genetic diseases, as well as burns and Stevens-Johnson
syndrome, can damage the ocular surface, especially the conjunctiva, by scarring. Although the conjunctiva
has substantial repair potential, these diseases are painful inflammatory diseases and the patients are
desperate for better treatments. Current treatments include use of redundant conjunctiva or amniotic
membrane. Development of novel biocompatible materials is providing improved treatments in the field of
regeneration medicine. For this proposal we will take advantage of the newly developed molecular layer
deposition (MLD) technique to build coatings of bioactive materials. Our overall goal is to develop a
transplantable and functional conjunctival construct consisting of the three types of human conjunctival
epithelial cells (undifferentiated, stratified squamous, and goblet) growing on our novel surface. The surface is
based on an MLD film deposited on a silk fibroin matrix that is easily manipulated for surgical transplantation.
For SA1 we will characterize the phenotype of conjunctival epithelial cells growing on MLD silk construct and
compare it with cells growing on amniotic membrane. For SA2 we will evaluate the function of the three types
of epithelial cells growing on our constructs of MLD silk in response to physiological stimuli of cell function and
compare them with cells growing on amniotic membrane. For SA3 we will measure the repair response to a
mechanical injury of the cells on constructs of MLD silk compared to amniotic membrane. Cell counting,
molecular, and immunofluorescence microscopy techniques will be used to evaluate amount and phenotype of
cell growth. Physical techniques will be used to determine construct strength. Ca2+ imaging, ELISAs for
MUC5AC secretion, and other physiological techniques will be used to determine function of cells on the
construct. Immunofluorescence microscopy and multi-cytokine measurements will be used to evaluate wound
healing. The final product of three types of conjunctival epithelial cells grown on MLD silk will be functional, and
transplantable and excellent for repair of the diseased and damaged conjunctiva.

Public health relevance
Project Narrative Ocular surface disorders, including infections and autoimmune and genetic diseases, as well as chemical/thermal burns can scar the ocular surface causing pain and impairing vision. We propose to develop a novel conjunctival equivalent for transplantation to repair the conjunctiva. We will create a three layered construct consisting of undifferentiated, goblet and stratified conjunctival epithelial cells growing on a film produced by a novel molecular layer deposition technique (MLD) using bioactive titanium combined with amino acids that is deposited on spin-coated matrices.